Regulation of blood flow in the brain by capillary KATP channels

PROJECT SUMMARY: Approximately 90% of the blood vessels in the brain are capillaries, which have been
traditionally viewed solely as a dense and passive network of tiny vessels which allow efficient nutrient and waste
exchange. More recently, the capillaries have been appreciated for their ability to sense brain
activity/environments and electrically communicate these signals with upstream arteries/arterioles to ensure
rapid and efficient blood flow regulation. The initiation and propagation of these hyperpolarzing electrical signals
in the capillaries requires activation of vascular potassium ion channels such as inwardly-rectifying K+ 2 channels
(Kir2). Recently, the ATP-sensitive K+ channel (KATP) channel has been functionally characterized in capillary
endothelial cells (cECs) and pericytes. The physiological stimuli which activate capillary KATP channels and
regulate blood flow in the brain are unclear. Furthermore, the electrical signaling and amplification processes
between pericytes and cEC are poorly understood. Drops in brain O2 concentration can occur in response to
many physiological and pathological conditions such as stroke, tumor growth, altitude change, and hypotension,
and consequently results in a metabolic challenge to cells and leads to accumulation of extracellular adenosine.
Both changes in cellular ATP and adenosine signaling can stimulate KATP channel function. Here, I hypothesize
that local and global hypoxic events stimulate capillary pericyte and cEC KATP channel activity and
hyperpolarization, the latter of which is amplified and propagates through cEC Kir2.1 activation to increase blood
flow. I will test this hypothesis with two distinct aims. First, I will elucidate the mechanisms by which capillary
KATP channels increase cerebral blood flow to hypoxia. Second, I will elucidate electrical coupling and
amplification processes within and between capillary pericytes and cECs during KATP activation. These aims will
be accomplished using newly developed animal models, electrophysiology in native isolated cells and intact
tissues, and advanced optical imaging in isolated tissue and whole animals.
Dr. Nicholas Klug has an ideal training history in vascular physiology, an exceptional environment in the
laboratory of Dr. Mark Nelson, and a high potential as an independent, NIH funded vascular researcher.
Dedicated mentoring from the mentoring committee of Dr. Mark Nelson and Dr. Andy Shih (University of
Washington) will provide Dr. Klug with new and expanded knowledge and tools in vascular physiology, optical
imaging approaches, and ion channel function and provide detailed professional guidance to distinguish himself
as an independent investigator. Collaboration with Dr. Christer Betsholtz and Dr. Yangguang Ou will provide new
models and tools to properly address the role of capillary sensing/signaling and adenosine release in vivo.
Ultimately, the K01 Award provides substantial structure and support which will place Dr. Klug in a strong position
for continuous R01-level support, his research will expand our understanding of the sensing and signaling
properties of capillaries within the central nervous system.

Public health relevance
PROJECT NARRATIVE Brain capillaries are the site of nutrient and waste exchange throughout the entire brain. Ubiquitous coverage of brain capillaries allows them to sense brain activity and modulate blood flow. Here I test the novel hypothesis that brain capillary pericytes and endothelial cells are equipped with KATP channels and are electrically coupled allowing them sense hypoxia and regulate blood flow.